INSULIN INFUSION ON PROTEIN AND GLUCOSE METABOLISM IN LOW BIRTH WEIGHT INFANTS

To determine the effect of insulin infusion on proteolysis in the very low birth weight infant. To determine if exogenous insulin, with serum glucose levels held relatively constant, will suppress endogenous glucose production and increase glucose utilization.